Administrative Core

The Administrative Core
The overall goal of the CardioPulmonary Vascular Biology (CPVB) COBRE program is to facilitate high impact
vascular biology research to accomplish our vision to develop effective approaches to prevent and treat vascular
diseases affecting the pulmonary and cardiovascular systems through better understanding of disease
mechanisms. During the past 9 years, the CPVB COBRE supported 13 research project investigators and 25
pilot project investigators, who published 237 unique manuscripts, and collectively brought in ~$62.4 million
dollars on 154 grants awarded following the COBRE support. Our technical cores provided state-of-the-art
equipment and technical services. The Administrative Core held 215 seminars. The feedback from our
investigators and users shows high level of satisfaction and continued need for pilot award and technical services
in CPVB. In Phase III, the Administrative Core will provide supervision, coordination, and management of the
entire range of center activities. Activities organized by the Administrative Core will foster strong scientific
advising, a vigorous career development program, and opportunities for interaction with visiting experts and will
enhance external research funding and expansion of the scientific scope of the CPVB COBRE. The Specific
Aims are to: i) provide leadership and direction with the assistance of the steering committee and the advisory
committees, and organize and manage administrative functions of the CPVB COBRE including committee
meetings, communication with stakeholders and research community, website maintenance, data collection for
investigator tracking and evaluation, financial management, and progress reports; ii) manage activities that
enhance career development of pilot project awardees, affiliated investigators, and vascular biology research in
Rhode Island; iii) manage, prioritize, and allocate fiscal resources in support of the entire range of CPVB COBRE
activities; and iv) track and enhance CPVB COBRE services and programs based on evaluation and feedback
to facilitate the transition to a sustainable center. It is anticipated that successful accomplishment of these aims
will result in a sustainable CPVB Center with high quality technical core services, significant institutional and
extramural funding support, and commitment to continue the development of effective approaches to combat or
resolve cardiopulmonary vascular diseases and to develop the careers of faculty to become national leaders in
biomedical research.